Probing mechanisms of long QT type 2-associated neuronal dysfunction using gene-edited stem cell-derived neurons

The overall objective of this proposal is to investigate cellular mechanisms by which long QT syndrome-
associated KCNH2 variants disrupt neuronal function. hERG1, encoded by KCNH2, is a developmentally-
regulated potassium channel that mediates cellular excitability. In the heart, loss-of-function KCNH2
variants cause the cardiac disorder long QT syndrome type 2 (LQTS2), and dramatically increase the
likelihood of cardiac arrhythmia and sudden cardiac death. KCNH2 is also expressed in the human brain,
but the mechanistic impact of KCNH2 variants on neuronal physiology has not been studied. Clinical data
show that LQTS2 patients carrying KCNH2 variants develop epilepsy at five times the rate of any other
LQTS-associated genes. Further, KCNH2 variants are enriched in cases of sudden unexplained death
in epilepsy (SUDEP). How KCNH2 variants predispose LQTS patients to epilepsy and SUDEP has not
been explored. There is therefore a critical unmet clinical need to define the mechanistic link between
hERG1 potassium channel dysfunction and neuronal hyperexcitability. Here, we will use neurons
differentiated from gene-edited and patient-derived human stem cells to determine molecular and cellular
mechanisms by which LQTS2-associated KCNH2 variants alter neuronal function. This project will
explore the confluence of cardiac and neuronal electrical activity and will provide the foundation for future
R01 level-funding.

Public health relevance
Project Narrative Patients with mutations in a protein called hERG1 develop epilepsy at a greater rate than the general population, but we don't know why. In this project we will study brain cells grown from patients with hERG1 mutations and compare them to brain cells grown from healthy individuals. This will allow us to identify mechanisms by which hERG1 mutations change brain cell behavior to promote epilepsy.